emuLAAte: atraumatic patient-specific stroke prevention technology

Project Summary:
Atrial fibrillation (AF) will affect >12 million Americans by 2030. AF leads to a 5-fold increased risk of stroke, a
leading cause of death and disability costing >$50 billion/year in the US. Over 90% of stroke-causing clots in AF
patients form in the left atrial appendage (LAA); thus, occlusion of the LAA (LAAO) offers a promising alternative
to long-term blood-thinners. However, LAAO is hindered by incompatibility between standard off-the-shelf
devices and real human patients. FDA-approved LAAO devices are metallic, round, and pre-fabricated in limited
sizes, whereas human LAAs are composed of complex, delicate tissues in a limitless range of shapes and sizes.
This fundamental geometric and mechanical incompatibility can lead to incomplete occlusion (~25-50% of
cases), challenging clinical workflows, tissue trauma, and suboptimal stroke prevention. To solve this, Spheric
Bio is developing the emuLAAte platform to assemble fully-soft, personalized implants directly inside the patient’s
body through a minimally-invasive approach. By delivering, forming, and stabilizing soft biomaterials at the target
site, we can generate atraumatic intracardiac implants that match each patient’s unique anatomy. This could
simultaneously address the persistent patient-device mismatch and device-anatomy alignment issues to improve
stroke prevention in a safer and simpler clinical workflow. To date, our team has already developed an initial
emuLAAte prototype, conducted early benchtop and acute large animal tests, and interviewed >100 LAAO
stakeholders. At this stage, the most critical technical and clinical risk is the reliable anchoring of the soft shape-
matching implant inside the intracardiac environment. Our Phase I project conclusively addresses this risk via
two aims. Aim 1: Design, characterization, and benchtop verification of a tissue-facing anchoring system that
supports transcatheter delivery and effectively engages and secures the 3D implant in the dynamic cardiac
environment. Aim 2: Two-phase validation study in a large animal (porcine) model: first phase demonstrating
acute anchoring success and second phase establishing long-term anchoring stability and preclinical safety
outcomes in a chronic trial. PI development: Holistic plan includes coursework, programs, and assignments to
learn and implement essential technology translation skills, augmented by regular engagement with diverse
mentors for critical personal and project feedback and exposure to different entrepreneurial perspectives. After
Phase I completion, we’ll have de-risked the most significant remaining engineering challenge and concretely
demonstrated technical feasibility and clinical potential for our emuLAAte platform in a living, beating heart.
Further, the PI will develop the skills and confidence to drive technology translation and establish a career as a
biomedical entrepreneur. Accordingly, Phase I provides a solid foundation to address further product design,
usability, manufacturing, and clinical deployment concerns in Phase II. Our approach for on-demand, in situ
formation of atraumatic patient-specific implants would be a paradigm shift in device-based stroke prevention for
the millions of patients living with atrial fibrillation.

Public health relevance
Project Narrative: Intracardiac structures display high patient-to-patient variability and are located in inaccessible tissues, making it difficult to effectively design and implant prefabricated off-the-shelf medical devices. This project will pioneer a transcatheter in situ implant formation technology to flexibly assemble form fitting 3D implants directly inside the patient’s own heart in a minimally invasive process. Successful completion will advance us toward our long-term vision: point-of-care formation of fully soft, patient specific intracardiac implants for safer, simpler, and more effective device-based stroke prevention.